Community Engagement Core

COMMUNITY ENGAGEMENT CORE-ABSTRACT
The NYC-MHESJ Community Engagement Core (CEC) plays a crucial role in addressing health disparities within
the diverse landscape of New York City, with a specific focus on racial and ethnic minorities residing in
underserved communities. Guided by community-based participatory research (CBPR) principles, the CEC
collaborates seamlessly with a diverse spectrum of stakeholders, including researchers, clinicians, and
community organizations, to actively contribute to reducing health gaps.
The Specific Aims of the Core are:
Specific Aim 1: The NYC-MHESJ CEC will be a trusted resource for NYC communities to address their
unique health challenges/disparities. By engaging new communities, fostering reciprocal relationships, and
providing mechanisms for communities to independently address health issues, the CEC actively supports and
advances the broader goals of NYC-MHESJ. This approach ensures that the collaborative efforts go beyond the
grant period, creating sustainable solutions and addressing the unique health challenges diverse communities
face.
Specific Aim 2: The NYC-MHESJ CEC will train and equip biomedical researchers to conduct HDR,
emphasizing community engagement. Through a comprehensive seminar series, the CEC equips scientists,
particularly NYC-MHESJ investigators, with the tools necessary to enhance community participation and
effectively address health disparities. The CEC's strategy includes simultaneous training for community
members and researchers and building strong relationships extending from hypothesis generation to
dissemination. By integrating community perspectives throughout the research process, the CEC mentors
investigators, enhancing their Community-Engaged Research (CEnR) skills across disciplines.
Specific Aim 3: The NYC-MHESJ CEC will contribute to the generation of new knowledge in the science
of Community Engaged Health Disparities Research (CEnHDR). The CEC actively facilitates CEnHDR
initiatives, collects data on engagement processes and outcomes, and refines methods to understand its impact
on research, researchers, and communities.

Public health relevance
Per Funding Opportunity Announcement (FOA) Number RFA-MD-24-001 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.